Targeting FMNL2/Rho-GTPase Pathway for IOP Regulation in Glaucoma

Abstract:
Primary open angle glaucoma (POAG) is a blinding disease world-wide, but for unknown reasons, persons
from West Africa and of West African descent including African-Americans are at disproportionate risk.
Dysfunction in aqueous humor outflow may lead to elevated IOP, which, if left untreated, can cause
blindness. Yet, very little is known about this disease in African Americans. Therefore elucidation of IOP
regulation in African Americans is a major hurdle that must be overcome before therapeutics for the treatment
of POAG in this population can be developed. Genome-wide association study (GWAS), identified a unique
genetic risk allele, the FMNL2 gene in African Americans with POAG. The FMNL2 gene encodes the formin-
related protein-2 (FMNL2) that modulates TM cell actin stress fiber assembly, thus regulating TM contractility
and IOP. Another protein, Cdc42-Rho GTPase regulates FMNL2 function. Contraction and relaxation of the
TM cells help to regulate IOP. Collectively, these findings suggest that FMNL2 dysfunction is likely to alter
actin stress fiber assembly and contribute to POAG. Given that scientific premise, the overall goal of this
grant to elucidate the cellular, molecular and biochemical mechanisms that regulate IOP in African Americans
aimed at identifying novel therapeutic targets for the treatment of glaucoma in that population. Our objective
is to determine how FMNL2 regulates the TM cell contractile apparatus and thus modulates IOP in African
Americans. Our global hypothesis is that dysfunction in FMNL2 in the African American population decreases
aqueous humor outflow and results in the development of POAG. The specific aims will test these
hypotheses: (Aim 1) Dysfunction of FMNL2 gene disrupts TM cell actin stress fibers and aqueous humor
outflow, causing glaucoma in African Americans. (Aim 2) Cdc42-Rho GTPase signaling pathway regulates
FMNL2-mediated TM contractility. In vitro and in vivo studies using human tissues will be utilized to
investigate the mechanism of IOP regulation in African Americans. This project is novel and significant and
its completion would for the first time, demonstrate in African Americans, 1) an IOP-regulatory mechanism,
2) a functional role for the FMNL2 gene in regulating physiological IOP and 3) a causative role for the FMNL2
risk allele gene in glaucoma. Identification of Cdc42-Rho GTPase/FMNL2 signaling pathway in African
Americans will provide new therapeutic targets for the development of treatments for glaucoma in African
Americans and other persons of West African descent that are at a high risk for development of the disease.

Public health relevance
Project Narrative Glaucoma is a blinding disease world-wide, but for reasons that are unclear, African- Americans are at disproportionate risk, yet, very little is known about this disease in this population. Therefore identification of IOP-regulation in African Americans is a major task that must to be overcome before therapeutic interventions for the treatment of glaucoma in this population can be developed. Therefore the overall goal is to elucidate the cellular, molecular and biochemical mechanisms that regulate IOP; African American and Non-Hispanic Whites donor eyes will be used in this study, aimed at identifying novel therapeutic targets for the treatment of glaucoma.